Mapping internal exposome-metabolome dynamics with advanced data science to identify environmental determinants of autism.

ABSTRACT
Neurodevelopmental disabilities among autistic people are an increasing public health concern in the U.S.
Current prevalence estimates indicate that 1 in 31 school-aged children have autism, and the increase in
recent decades strongly supports environmental factors as key contributors. However, there have been
no systematic studies of complex environmental exposures contributing to the likelihood of developing
autism. Leveraging a powerful untargeted high-resolution mass spectrometry (HRMS) approach and two
large, multi-site autism studies from the U.S. that already include extensive genetic, omics, questionnaire,
targeted exposure, and phenotype data, we will create the largest exposome database for autism and an
Autism Exposome Atlas well-powered for foundational discovery analyses of non-genetic factors driving
autism outcomes, including the role of critical developmental periods and familial studies supporting
differentiation between shared environmental and genetic influences. The exposome represents
cumulative life-long environmental exposures that produce biological response signatures influencing
health; exposome characterization is widely recognized as the greatest unmet challenge in children’s
environmental health. Our team is at the forefront in developing critical advances in HRMS methodologies
and algorithms for chemical detection, high-dimensional approaches for biomarker selection, and
advanced mixtures statistics that address the complexity of the real-life environment. We are thus poised
to conduct cutting-edge exposomic research on environmental drivers of autism-associated health
outcomes. In support of the Autism Data Science Initiative (ADSI) Tasks II and III, we will apply these
approaches to establish dynamic exposome-metabolome signatures of autism outcomes. We will
leverage children and parent biospecimens collected from participants enrolled in the Early Autism Risk
Longitudinal Investigation (EARLI) and the Study to Explore Early Development (SEED) cohorts to 1)
Develop a comprehensive database of environmental, dietary, and chemical biomarkers that influence
autism development; 2) Assemble a unified Autism Exposome Atlas through comprehensive and high-
throughput chemical exposome profiling of 7,812 blood samples (including autism cases and their
parents) for profiling of environmental, dietary, pharmaceutical, and endogenous metabolite biomarkers;
3) Identify exposome biomarker profiles of autism development, and 4) Integrate exposure and biological
response pathways to uncover mechanisms underlying autism across different windows of susceptibility.
Our results will identify critical exposome biomarkers for autism and determine how exposure and
biological response contribute to neurodevelopment and symptom heterogeneity. We will develop a
transformative Autism Exposome Atlas providing a centralized and organized resource for evaluating
familial and cross-sectional exposome signatures and corresponding functional relationships with
underlying biological response signatures. Assembly of the Autism Exposome Atlas will accelerate
identification of key environmental predictors of autism and provide the evidence needed to prioritize
public health interventions to support child neurodevelopment and improve health and well-being among
autistic people.